Administrative Core

Drs. Ji and Maixner will serve as co-Program Directors and will form the Administrative Core for the Program. With the assistance of the CTPM administrative staff (Beth Peloquin and Shirley Morton), this Core will coordinate the administrative activities of the Program and of the individual subprojects and cores (i.e., assist in the management of budgets and personnel). The Administrative Core has three units, the administrative unit, the biorepository unit, and the bioinformatics and statistical unit. Dr. Maixner will also oversee biorepository unit, as well as bioinformatics and statistical unit managed by two experienced statisticians Drs. Andrey Bortsov and Shad Smith. Biorepository unit will implement and oversee the management of the biobanking of tissues generated by the Molecular Core and individual subprojects. The Administrative Core will also be responsible for compliance with NIH policies on data sharing and submission of an annual progress report and NIH program renewal applications, coordinating the CTPM Seminar Series and arranging visits by our External Advisory Committee as well as meetings with the Internal Advisory Committee. The Administrative Core will create an infrastructure to assure that the Program Project enhances the synergy of the individual subprojects and affiliated cores, as well as Scientific Rigor and Reproducibility. It will be responsible for the day-to-day management of the Program. In addition, this core will assist in maintenance of a website for the program and Center. Notably, all the program members ? Drs. Ji, Maixner, Jordt, Niccolo, Nackley, Liedtke, Smith and Bortsov are affiliated with CTPM and will have their labs and offices in the new research building (MSRB III), which will be ready for moving in June, 2018. The new NCCIH center of excellence (same as CTPM) will occupy the entire 6th floor with 16,000 sq. ft. and a conference room for 45 people. The start-of-art conference room on the 6th floor of MSRB III is fully equipped for seminars, meetings, and tele-conferences.